Molecular Imaging and Metabolotheranostics of PDAC-Induced Cachexia

Cachexia induced by pancreatic ductal adenocarcinoma (PDAC) results in significant morbidity, mortality, and
poor response to treatment including immune therapy. We intend to apply our molecular and functional imaging
capabilities, and our experience in developing theranostic nanoparticles (NPs) that deliver small interfering RNA
(siRNA), to focus on reversing PDAC-induced cachexia. We found that a cachexia inducing PDAC xenograft
induced profound changes in brain, plasma and tumor interstitial fluid glutamine levels that led us to focus on
the glutamine/glutamate axis and disruption of glutamine metabolism in Aims 1 and 2 of this application. Our
preliminary data with human plasma and human PDAC tissue further support targeting the glutamine/glutamate
axis. Of all the visceral organs, the spleen showed the highest number of metabolic changes and the largest
weight loss with cachexia. Downregulating the glutamine transporter, SLC1A5, significantly reduced body weight
loss compared to empty vector or wild type tumors of similar volumes, and normalized spleen weights to those
of normal non-tumor bearing mice or mice with non-cachexia inducing tumors. Since the spleen is a major
reservoir of immune cells, the splenic weight loss and metabolic alterations have prompted us to focus on the
spleen and tumor immune environments with cachexia, and following disruption of glutamine metabolism, in Aim
3. In Aim 1 we will focus on the glutamine/glutamate axis, studying preclinical PDAC models in immune
suppressed as well as immune competent mice with SLC1A5 and glutaminase 1 and 2 (GLS1/2) downregulated.
These studies will expand our understanding of the effects of downregulating these target genes on cachexia,
and on tumor and organ metabolism using 1H magnetic resonance spectroscopy (MRS), transcriptomics, and
molecular characterization. In Aim 2, we will downregulate these target genes in established wild type tumors
using biocompatible dextran siRNA NPs that can be imaged to detect tumor delivery and biodistribution. We will
also evaluate a pharmacological inhibitor of SLC1A5, V-9302, and of GLS, CB-839, and determine the effects of
treatment with siRNA NPs and of pharmacological inhibitors on cachexia and on tumor and organ metabolism
using 1H MRS. CB-839 is already in clinical trials for solid cancers, presenting a more immediate strategy for
reversing or reducing cachexia. In Aim 3 we will investigate changes in T-cell exhaustion and myeloid derived
suppressor cells combined with metabolic changes in the spleen and tumor with or without glutamine disrupted.
Mass spectrometry imaging will be used to relate spatial metabolic information to immunostaining. Studies in
Aim 3 will include investigating paired spleen and tumor tissue from PDAC patients with or without weight loss
and loss of muscle mass as identified in CT scans. The three aims are designed to advance understanding of
the consequences of cachexia on organ metabolism and the immune microenvironments in the spleen and
tumor, and the role of glutamine metabolism disruption on reversing or reducing these consequences.

Public health relevance
Cachexia occurs with high frequency and severity in pancreatic cancer, causing significant morbidity and lower tolerance to chemotherapy and poor response to immune therapy. Our three aims will be performed with preclinical pancreatic cancer models in mice and with human tissues from pancreatic cancer patients. We will use molecular imaging including high-resolution 1H magnetic resonance spectroscopy and mass spectrometry imaging to expand our understanding of pancreatic cancer-induced cachexia, to develop siRNA metabolotheranostic strategies with a focus on the glutamine/glutamate axis to reverse pancreatic cancer- induced cachexia, and to understand the role of cachexia and glutamine metabolism disruption in altering spleen and tumor immune environments.